ACTG240 TRIAL OF ZDV VS D4T IN CHILDREN WITH HIV INFECTION

To evaluate the safety and tolerance of stadovudine in treatment of children with acquired immunodeficiency syndrome or clinical symptoms associated with HIV infection.